Targeting SARS-CoV-2 induced lung immunopathology using novel genetic mouse models

Lung immunopathology is a major cause of the morbidity and mortality associated with the SARS-CoV-2
infection. Accumulating evidence suggests that SARS-CoV-2-associated lung damage is caused not only
by the virus, but also by excessive production of proinflammatory cytokines, known as cytokine storm.
Although available vaccines and antiviral drugs protect against infection, these strategies do not specifically
target immune-mediated pathology. Therefore, uncoupling anti-viral host defense mechanisms from the
immunopathology induced by these mechanisms, represents a novel therapeutic strategy for COVID-19
treatment. However, to develop such strategies, a better understanding of the fundamental mechanisms that
regulate SARS-CoV-2-induced immunopathology using animal models of COVID-19 disease is critical. The
critical gap is limited therapeutic approaches that specifically target immune-mediated pathology and
availability of animal models that recapitulate human lung disease. Experiments with mouse models
expressing SARS-CoV-2 receptor, human ACE2 (hACE2) demonstrated virus invasion to the brain and
multiple organ pathology with limited lung pathology, which does not fully recapitulate acute respiratory
distress syndrome in patients with severe COVID-19 disease. Our ongoing results demonstrate that
lymphotoxin beta receptor (LTR)-deficient mice are protected from SARS-CoV-2-induced
immunopathology. We also found that LTβR promotes cytokine storm and lung damage in another model
of respiratory disease, influenza infection. The objective of this proposal is to develop novel mouse models
that mimic lung disease of COVID-19 patients and to test the efficacy of LTR inhibitor to block SARS-CoV-
2-induced lung damage. Our central hypothesis is that expression of hACE2 in type II alveolar epithelial
cells is required for SARS-CoV-2 induced lung disease and that LTR antagonist inhibits SARS-
CoV-2 induced lung immunopathology. To test this hypothesis, we propose two specific aims. In Aim 1,
we will generate mice with regulated hACE2 expression in type II alveolar epithelial cells using CRISPR-
Cas9 system. We will infect these mice intranasally with SARS-CoV-2 and evaluate lung immunopathology
and cytokine expression. In Aim 2, we will test the effectiveness of LTR antagonist to block SARS-CoV-
2-induced immunopathology. We will optimize dose and timing of LTR inhibitors and evaluate lung
immunopathology, viral replication, cytokine production, and protective immunity. This proposal is innovative
and significant, as it will generate novel animal models to study SARS-CoV-2 pathogenesis, provide deeper
understanding of the mechanisms regulating virus-induced immunopathology and test the feasibility of
targeting novel immune regulator, LTR, to inhibit SARS-CoV-2 induced immunopathology without limiting
protective immunity.

Public health relevance
Lung immunopathology induced by SARS-CoV-2 infection is a major cause of morbidity and mortality. The specific aims of this proposal are designed to develop novel mouse models of SARS-CoV-2 induced lung disease and define the role of lymphotoxin beta receptor in pathogenesis of SARS-CoV-2-induced lung immunopathology. The proposed research is relevant to public health because it will provide a deeper understanding of the fundamental mechanisms controlling lung immunopathology and will help in developing new strategies to treat respiratory disease.